Training Program in Perinatal Biology and Medicine

DESCRIPTION (provided by applicant): This training program provides basic and clinical-translational research training for Neonatology and Maternal- Fetal Medicine physicians (board eligible or certified in their primary specialty) and Basic Scientists who have completed a PhD degree. The research training includes concepts and techniques in perinatal/developmental physiology, biochemistry, and cell and molecular biology. Training is for 2-3 years in preparation for academic careers in reproductive medicine within departments of Pediatrics and Obstetrics &-Gynecology or in basic science departments with direct links to the clinical departments. Trainees will be appointed after demonstrating research commitment and accomplishment during their 1st 2 years of fellowship/postdoctoral training, which will be balanced by 4th and/or 5th years of training as Fellow/Instructors but with Assistant Professor salaries. During the first year in the T32 program, trainees work with faculty advisors to select basic research projects and mentors. Research mentors, projects, and labs are selected among current T32 faculty, but include the breadth of faculty and research opportunities and facilities on the UCD Medical Campus. Each area includes clinical- translational, whole animal, organ, cell, and molecular research so that a trainee can participate at any one or several levels of biological investigation. Trainees attend seminars that review intrauterine development and fetal, maternal, and neonatal physiology. Courses in the graduate school dealing with cell culture, genetics, developmental biology, cell and molecular biology, isotope applications, biostatistics, data processing and informatics, statistics, graphics and imaging, bioethics, and ethical conduct of research are included. Seminar programs in research design and abstract and manuscript preparation are provided. The 2nd and 3rd years are devoted to the completion of the research projects begun in the 1st year and expansion into new areas of research and new research techniques. Each trainee develops institutional animal and clinical research protocols to address technical and ethical issues involved in human and animal research. Trainees plan and conduct their research projects as independently as they can, but with full faculty mentoring. This program provides multidisciplinary training in basic and clinical-translational biological investigation, integrating state-of-the-art research techniques with important questions in perinatal medicine and biology. This approach equips the trainees with the capacity to move independently and successfully into academic careers in either basic or clinical-translational science. Over many years, graduates of this training program have achieved high academic positions nationally and internationally and have had major impact on developing and supporting research training programs. Such ultimate research/academic leadership is a major aim of this program. PUBLIC HEALTH RELEVANCE: The primary purpose of this Training Program is to develop academic leaders among Neonatologists, Maternal- Fetal Medicine (MFM) Specialists, and Basic Scientists who know how to work together collaboratively and who have the capacity, based on personal meritorious accomplishment in research, to identify, understand, and solve important problems in reproductive (perinatal) biology and medicine. Research accomplishment and academic achievement are intimately intertwined goals and are fundamental and inseparable for achieving academic and research success. Through top academic leadership positions, our graduates have made major national impact on research program development and support.

Public health relevance
PROJECT NARRATIVE The primary purpose of this Training Program is to develop academic leaders among Neonatologists, Maternal- Fetal Medicine (MFM) Specialists, and Basic Scientists who know how to work together collaboratively and who have the capacity, based on personal meritorious accomplishment in research, to identify, understand, and solve important problems in reproductive (perinatal) biology and medicine. Research accomplishment and academic achievement are intimately intertwined goals and are fundamental and inseparable for achieving academic and research success. Through top academic leadership positions, our graduates have made major national impact on research program development and support.